Neural Mechanisms of Tactile Sensation in Rodent Somatosensory Cortex

DESCRIPTION (provided by applicant): How the brain's cerebral cortex functions, and how this function goes awry in diseases like autism and mental retardation, remain unknown. A powerful model system to investigate cortical function is the whisker somatosensory cortex (S1) of rodents. Rodent S1 is a canonical primary sensory area whose cellular and circuit properties are known in remarkable detail, but how these circuits process sensory information is unknown. We propose to investigate how S1 encodes and processes sensory information, which is a critical step to developing an integrated, cellular-to- systems level understanding of cortical function. The resulting description of normal sensory cortical function will help identify the processing defects in autism, mental retardation, and other neurological disorders. To study sensory processing, we focus on sensation of surface texture, which is a basic component of tactile sensation. We will study quantitatively how surface texture is transformed into a pattern of vibrations by the sensory periphery (the whiskers, which function similarly to human fingertips), and encoded by action potentials in populations of neurons in S1. We use the gold-standard technique of quantitatively comparing psychometric, neurometric, and whisker kinetic-based sensory discrimination functions to identify potential sensory codes for texture. In addition, we use modern optogenetics techniques to activate cortical neurons using light, which allows us to perturb neural activity in S1 and determine how different features of cortical spike trains provide sensory information to the animal. Together, these studies will identify the physical and neurobiological signals that convey information about surface texture in somatosensory cortex. This work will contribute to understanding the nature of cortical information processing, and how it is implemented by specific neurons, circuits, and synapses in S1. Conservation of primary sensory cortical function across mammals suggests that principles of sensory processing identified here will be relevant to the human brain. Because rodent S1 is a major disease model for Fragile X mental retardation, epilepsy and other disorders, our work could help establish how these diseases impair cortical function. This work may be particularly relevant for autism, which involves deficits in vibrotactile processing, and whose circuit basis may be revealed by studying defects in S1 processing in rodent models.

Public health relevance
PUBLIC HEALTH RELEVANCE: This research will identify how the cerebral cortex encodes and processes tactile (touch) inputs, using a rodent model system. Such baseline knowledge about normal cerebral cortex function is critically needed to understand cortical processing defects in autism, mental retardation, and other neurological diseases. Project Narrative This research will identify how the cerebral cortex encodes and processes tactile (touch) inputs, using a rodent model system. Such baseline knowledge about normal cerebral cortex function is critically needed to understand cortical processing defects in autism, mental retardation, and other neurological diseases. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS How brain circuits process sensory information to guide perception remains unsolved. To address this, we will study sensory coding in the whisker somatosensory cortex (S1) of awake, behaving rats. Rat whiskers are active tactile (touch) sensors, and the whisker system has major advantages for determining basic principles of tactile sensation and sensory cortex function. Understanding neural coding in rodent S1 will help extend the detailed knowledge of S1 cellular and circuit properties to build an integrated, cellular-to-systems understanding of sensory cortex. The results will provide a baseline description of sensory cortical function that is needed to identify the processing defects in autism, mental retardation, and other disorders. To study sensory processing, we focus on sensation of surface texture. Whisker scanning across surfaces produces complex, surface-induced whisker micromotions (kinetics) including discrete, high-velocity whisker slips, but how different kinetic features encode surface properties, and how these signals are processed in S1, remain unknown. We will study the whisker kinetic features that encode surface texture (roughness) in awake, behaving rats and how these features are represented in S1 spike trains. Then, we will use optogenetic perturbation of spike trains to determine which spike train features convey texture information to the animal. In Aim 1, we quantitatively distinguish between three competing models of texture coding. In one model, whisker micromotions have greater mean speed on rough vs. smooth surfaces, and S1 neurons fire in proportion to mean speed, implementing a firing rate code for texture. In a second model, discrete, high-velocity whisker slips are the fundamental cue for texture, and slips are reflected in S1 by synchronous volleys of precisely timed slip-evoked spikes, whose frequency and/or temporal pattern encode texture. In a third model, each whisker is tuned by mechanical resonance to vibrate best during whisking on a specific texture, and texture is encoded by the ratio of motion across whiskers with different resonance frequencies, and by relative firing rates in the corresponding S1 columns. We will distinguish these models using the gold-standard approach of measuring whisker motion and S1 spiking in awake, behaving rats performing texture discrimination, and quantitatively comparing psychometric, neurometric, and whisker kinetic-based discrimination functions. This approach is used extensively in primates to validate specific sensory codes, and here we will apply it to rodent sensory behavior. In Aim 2, we will conduct a second, independent test of how texture is encoded by S1 spiking, by modulating S1 spiking using optogenetic techniques in behaving rats performing texture discrimination. By expressing channelrhodopsin (ChR2) selectively in S1 excitatory cells, we will stimulate S1 firing in specific patterns and whisker columns, and measure how this alters the rat's discrimination. We will test whether texture perception is altered more by an increase in sustained firing rate (consistent with mean speed theory) or by a series of brief, synchronous spike volleys (consistent with slip-stick theory), and whether perception can be biased towards rougher or smoother textures by altering the relative activation of short- vs. long-whisker columns (consistent with the differential resonance theory). Preliminary data show that we can express ChR2 in S1 neurons and drive spikes in vivo, indicating feasibility of this approach. Together, these studies will identify the physical and neural signals that convey information about surface texture in S1. This would constitute a major step towards understanding how cortical circuits process sensory information. Aim 1. Identification of sensory and neural parameters underlying texture discrimination 1.1 Measure the psychophysical function for texture discrimination with the whiskers. 1.2 Are cross-whisker comparisons required for texture discrimination, as predicted by the differential resonance theory? 1.3 Which whisker kinetic parameter best explains discrimination performance? 1.4 Which neural activity parameter in S1 best explains discrimination performance? Aim 2. Test texture coding models using optogenetic perturbation of S1 activity with ChR2 2.1 Develop light stimulation protocols to drive sustained firing vs. brief synchronous volleys in S1 in vivo 2.2 Can light-evoked ChR2 activation drive behavioral detection in a simple detection task? 2.3 Does ChR2-evoked firing bias texture perception consistent with mean firing rate or impulse codes? 2.4. Does ChR2-evoked firing bias texture perception consistent with the differential resonance theory?